UniProt - Protein sequence and function embeddings for AI/Machine Learning readiness

PROJECT SUMMARY
UNIPROT PROTEIN SEQUENCE AND FUNCTION EMBEDDINGS FOR AI/MACHINE LEARNING
READINESS - SUPPLEMENT REQUEST 2022
Artificial intelligence and machine learning (AI/ML) has the potential to advance biomedical research. The
overall goals of this Supplement application for the UniProt parent grant (U24HG007822) are to (i) support
the AI/ML community by providing protein sequence embeddings and make use of these embeddings for
accurate and fast protein clustering in UniRef production, (ii) explore methods of embedding UniProt
functional annotation data, and (iii) engage with the AI/ML community to advance AI/ML readiness of UniProt
data. UniProt has been a leader in the provision of protein sequence and annotation data since its inception
in 2002. UniProt provides gold standard training data for hundreds of AI/ML applications in biomedical
research. Protein sequence embeddings show enormous promise for protein clustering and structural and
functional analysis and prediction. By providing UniProt protein sequence embeddings, we will increase the
accessibility of sequence embeddings, reduce duplication of effort in the community, and establish a standard
that can facilitate evaluation and comparison of models. We will test different embedding methods, focusing
on the most widely adopted methods as determined by our recent survey of the user community. We will also
investigate using sequence embeddings to speed up sequence clustering in UniRef production. Similarly,
there are many functional annotations in UniProt that are amenable to embedding for use in AI/ML models.
As a test case, we will explore embedding of Rhea biochemical reaction annotations for enzymes and
transporters. In addition to disseminating the embeddings, we will develop methods to visualize them and
compare them to existing enzyme classification systems. Finally, to ensure that our work aligns with
community needs, we will organise a workshop to work with the community on their use cases and
applications for embeddings. We will invite various stakeholders, including researchers that participated in
the embeddings survey, participants of the metal binding site prediction challenge currently underway as part
of the parent grant, as well as NIH representatives. Overall, the work in this proposal will enhance the
readiness of UniProt for use in AI/ML and will integrate AI/ML methods into UniProt production.

Public health relevance
PROJECT NARRATIVE UNIPROT PROTEIN SEQUENCE AND FUNCTION EMBEDDINGS FOR AI/MACHINE LEARNING READINESS - SUPPLEMENT REQUEST 2022 Artificial Intelligence/Machine Learning (AI/ML) methods are becoming increasingly important to our understanding of proteins in health and disease, providing insight into areas such as the molecular basis of diseases and drug design and repurposing. The Universal Protein Resource (UniProt) contains a wealth of protein sequence and functional information, which is critical for building high-quality protein-related AI/ML models. In this project, we will pre-process and disseminate UniProt data so that it is easily accessible to developers in an AI/ML-ready format.